Temporal program for cell fate specification in the mouse embryo

SUMMARY. The first cell fate decision in mammals transforms a totipotent embryo comprising identical cells into
two cell types: outer trophectoderm cells, which will give rise to the placenta, and inner pluripotent cells, which
will give rise to the fetus. This decision depends on cell polarization. Although we understand how cell
polarization connects to downstream signaling to specify the two cell types, the mechanisms that act earlier, to
ensure cell polarization and its specific developmental timing, remain entirely unknown. To identify this
mechanism, we first need to identify the upstream regulators, which have been elusive – until now. We recently
found that two zygotically expressed transcription factors, Tfap2c and Tead4, together with Rho-mediated
actomyosin activity, are essential and sufficient to trigger de novo cell polarization. These results provide us with
an unprecedented opportunity to determine the mechanism that triggers the specific developmental timing of
embryo polarization in early mammalian development. The objective of this proposal is to reveal the principles
of self-organization that lead to de novo polarization and consequently the first cell fate specification in the key
model mammalian embryo, the mouse embryo. Our central hypothesis is that zygotic transcription cooperates
with the cytoskeleton to polarize cells and drive the first cell fate determination. We will test this hypothesis via
the following Specific Aims: Aim 1: To determine what regulates timing of embryo polarization. We
hypothesize that the timing of embryo polarization is controlled by Tfap2c and Tead4. We will alter the dose and
developmental stage of Tfap2c and Tead4 expression and examine the effects on their downstream targets and
the timing of embryo polarization. Aim 2: To determine how the apical domain becomes established. We
hypothesize that Tfap2c and Tead4 regulate apical domain formation by modulating the actomyosin
cytoskeleton, which in turn controls the conjugation of Par complex clusters. We will use advanced imaging
techniques and pharmacological and optogenetic methods to determine the role of the actomyosin cytoskeleton
in regulating apical domain formation and the dynamics of the Par complex during polarization. We will also
examine how Tfap2c and Tead4 control the behavior of the actomyosin cytoskeleton and the organization of
apical proteins into clusters to form the apical domain. Aim 3: To determine how altered timing of polarization
affects embryo development. Embryo polarization always happens at the late 8-cell stage, just before the first
cell fate decision, suggesting that the invariant timing of this polarization is critical for subsequent developmental
progression. We will determine if accelerating the timing of embryo polarization by one cell cycle at the pre-
implantation stage affects subsequent development, specifically cell fate and blastocyst formation before
implantation and embryo morphogenesis post-implantation. We expect to discover the triggers and mechanisms
that regulate the precise timing of cell polarization in the mouse embryo. Our work will likely have major medical
relevance, as it will shed light on the causes of early developmental defects and pregnancy loss in humans.

Public health relevance
PROJECT NARRATIVE. Successful formation of embryonic and extra-embryonic tissues is a prerequisite for further successful development. The overall aim of this application is to reveal the principles of self-organization that lead to de novo polarization and consequently the first cell fate specification that leads to the segregation of embryonic and extra-embryonic tissues in the key model mammalian embryo, the mouse embryo. These studies will identify mechanisms underlying the very early stages of mouse development and will likely have major medical relevance in the prevention of pregnancy loss in humans.